Synthesis of Neurologically Active Small Molecules

Project Summary/Abstract The understanding of normal cognitive function and the development of treatments for neurodegenerative diseases have been enabled by the study of natural products and their synthetic congeners. The extensive discoveries made in this realm have been limited primarily to the specific activities of abundantly available natural products or simple derivatives thereof. The long-term goal of this proposal is to use fragment-coupling approaches to synthesize varied, stereochemically rich, polycyclic natural product architectures with the potential to further the understanding of neurodegenerative disorders. products, death precursors, differentiated this recently two families of the grayanotoxins and the limonoids, both of which have been shown to attenuate neuronal cell caused by reactive oxygen species. By departing from conventional strategies that cyclize linear this proposal utilizes the convergent and scalable assembly of building blocks into structurally scaffolds . In line with conventional approaches, the molecular architectures obtained through approach will be subsequently modified through the application of a dehydrogenation methodology reported by our laboratory, as well as by other chemical strategies. This proposal outlines two convergent approaches for the synthesis of natural Novel reactive analogs produced by these routes will be evaluated for their ability to alleviate the effects of oxygen species on neurodegeneration.Through increased understanding of neurodegeneration on a molecular level, potential avenues for drug discovery and therapeutic intervention will be revealed.

Public health relevance
Project Narrative The aging population in the United States considerably exacerbates the economic and societal impacts of neurodegenerative disorders, which are among the leading causes of disability in the elderly. Advances in the drug discovery process, including in this area, have been enabled by the development of chemical routes to therapeutics based on natural products. The proposed research will focus on the development of synthetic routes to structurally complex natural products that have been shown to diminish the production of reactive oxygen species that are implicated in neurological disease.